The Eleanor M. Saffran Conference on Cognitive Neuroscience of Rehabilitation of Communication Disorders

Project
Summary.
The overall goal of this conference is to create an environment that fosters conversation among scientists, clinical
practitioners, educators and students who share a common interest in rehabilitation of communication disorders.
In addition, this year we continue our commitment to making a concerted effort to honor the principle of “Nothing
about us without us” by intentionally including people with lived experience of the conditions that are the subject
of discussion. This year, our theme is about the role of caregivers and companions of people with chronic
conditions that compromise language and/or communication abilities. We will be holding several panel
discussions on Day 2 of this meeting. The panels will each include people who have served as caregivers and
advocated on behalf of caregivers. The core of this conference is its ongoing focus on translational and
implementation science as it applies to language and communication disorders in adults and children. We
continue this focus and provide means for students and professionals who attend this meeting incorporate the
translational/ implementation model into their `thinking' as they progress through their education and move
forward in their clinical and/or research careers.

Public health relevance
This year's conference goals are fully aligned with the NIH/NIDCD objective to improve the diversity of the research workforce and the conference faculty and student scholar awardees represent a racially, and ethnically diverse group. We are encouraged that NIH/NIDCD provides these diversity supplements in recognition that achieving this goal has costs. We believe that the funds we have requested here will catalyze meaningful progress toward that end and provide an enriching experience for students who aim to include research as part of their career goals.